Oligodendrocyte Lineage Cell Mechanisms of Axon Selection for Myelination

PROJECT SUMMARY
Oligodendrocytes are the resident myelinating cell type of the central nervous system. Recent work indicates
that different classes of neurons have differing patterns and distribution of myelin along their axons. Yet only
recently has the identity of the axons been considered with respect to myelination. Thus, the mechanisms of
axon signaling and selection for myelination remain largely unknown. Our lab and others have shown that
neuronal activity increases myelination and synaptic vesicle release occurs along axons underneath myelin
sheaths, suggesting oligodendrocytes may need to be able to receive and interpret neurotransmitter signaling.
A single oligodendrocyte can myelinate up to 40 distinct axons, posing a unique situation where an individual
cell may need to adapt to signaling from many different neurons. How might this be achieved? Oligodendrocytes
express many canonical post-synaptic factors, ostensibly to aid in signaling between the axon and myelin sheath,
but the role these proteins play in myelinating cells is largely unknown. Using a zebrafish model, this proposal
will utilize genetic approaches and in vivo imaging to address two fundamental concepts: is there a pattern to
the expression and/or localization of these post-synaptic factors in oligodendrocytes and does this correspond
to wrapped axonal identity; and what function do they serve in the process of myelination. This will be achieved
in two aims: Aim 1 tests what post-synaptic factors are expressed, where these post-synaptic proteins localize,
and when are they important; and Aim 2 tests how these proteins function to facilitate myelination, and if there
is a correlation between axon identity and localization and function of post-synaptic proteins in myelinating
oligodendrocytes.

Public health relevance
PROJECT NARRATIVE Axon myelination is a critical component for circuit function and overall neuronal health, and loss of myelin can result in sensorimotor and cognitive impairments. This proposal seeks to understand the molecular mechanisms oligodendrocytes use to select axons of distinct classes and coordinate formation of appropriate amounts of myelin. These experiments can gain insight as to whether oligodendrocytes use different mechanisms to myelinate axons of distinct classes and may reveal that myelin sheath protein composition might be unique to axon identity.